Integrating the Exposome into Longitudinal Multiomics Profiling

PROJECT SUMMARY/ABSTRACT
This is an application for a K08 award for Sophia Miryam Schüssler-Fiorenza Rose, MD, PhD, a Physical Medicine and
Rehabilitation physician with subspecialty certification in Spinal Cord Injury Medicine and a Population Health Scientist.
Her long-term goal is to lead a multidisciplinary research team that can apply complex systems approaches and other novel
analytic methods to address the effects of adverse exposures on neurorecovery and long term health in those affected by
neurotrauma and related diseases.
This K08 award will provide Dr. Rose the support necessary to accomplish the following educational goals.
1. Develop expertise assessing the environmental, psychosocial and internal exposome. 2. Develop expertise in assessing
biological effects of exposures using longitudinal multiomics profiling. 3. Develop advanced skills in longitudinal
multiomics data analysis, complex systems and causal modeling approaches. 4. Develop skills in leading multidisciplinary
research teams. 5. Develop translational skills and design a study to validate some of the findings of the research in a clinical
or population based sample that will serve as a launching point for her independent research career.
To achieve these goals, Dr. Rose has assembled a mentoring team comprised of the following experts: Dr. Michael Snyder
(primary mentor) is a leader in the field of personalized medicine who has established a unique cohort undergoing
comprehensive, state-of-the-art, multiomics profiling with frequent longitudinal sampling. He provides access to this rich
data repository as well as laboratory support for novel analyses. Dr. Mark Cullen is director of the Stanford Center for
Population Health Sciences and leader of Stanford Precision Health for Ethnic and Racial Equity Center which focuses on
using precision-medicine tools to improve the health of underserved ethnic and racial groups. Dr. Cullen brings considerable
experience in integrating data on toxic exposures, psychosocial exposures and behavioral measures to understand how
different aspects of the exposome act in combination to produce positive and negative outcomes. Dr. David Rehkopf is an
expert in life course epidemiology and advanced longitudinal, nonlinear and spatial data analysis methods. Dr. Marc
Feldman is an expert in complex systems and mathematical biology whose work in quantitative cultural evolution combines
tools from multiple disciplines to understand the combined roles of culture and genes in shaping human evolution. Dr.
George Slavich is an expert in stress assessment, social genomics and psychoneuroimmunology.
The specific aims are as follows: Aim 1. Add a targeted assay for persistent organic chemicals (POCs) as a measure of POC
exposure to the study and characterize relationship to the internal exposome, adversity and stress exposures. Aim 2. Evaluate
the longitudinal trajectories of POCs and their covariation with clinical and omics measures. Aim 3. Integrate longitudinal
multiomics data and multiple perturbation data to create a Complex Systems - Causal Network model to evaluate the joint
effects of POCs and other exposures on impaired glucose regulation.

Public health relevance
PROJECT NARRATIVE The proposed research incorporates measures of environmental pollution exposures and adverse life experiences into a personalized medicine study. We specifically focus on how these exposures may lead to unhealthy levels of blood sugar and increase the risk of diabetes. Since environmental exposures are complex, we seek to develop a model that includes the effects of multiple exposures and that can be used to identify the most fruitful points of intervention to improve health.